Modulation of pathogenic T cells in EAE

Project Summary
Multiple sclerosis (MS) is a disease characterized by inflammation, demyelination, and neurodegeneration of the
central nervous system (CNS). Human genetic studies and adoptive transfer experiments in experimental
autoimmune encephalomyelitis (EAE), an animal model of MS point to CD4+ T helper cells as important actors
in the development and progression of CNS specific autoimmunity. IL-2 is a cytokine critical for maintaining T
cell homeostasis, growth, and proliferation. IL-2 is predominantly produced by activated CD4+ T cells in lymphoid
organs. However, this production is lost in most cells and only sustained in a unique fraction of CD4+ T cells.
We have developed a novel tool which allow us to track, eliminate and study IL-2+ T cells during the development
and progression of EAE. Here, we will determine the identity, characteristics and means to modulate IL-2+ T
cells in the context of EAE development and progression and establish whether STAT1 limits IL-2+ T cells and
their pathogenic functions. The completion of these studies will provide new insights on the function of IL-2+
cells during prolonged disease progression, establish whether the enhance STAT1 signaling can limit the
pathogenic function of these cells, and identify markers of pathogenic IL-2+ T cells and pathways that can be
further studied and targeted to limit the activity of these cells in the context of CNS autoimmunity.

Public health relevance
Project Narrative The production of IL-2 is tightly regulated and few CD4+ T cells maintain IL-2 expression. The importance and characteristics of these cells during CNS autoimmunity has not been determined. In this proposal, we will use novel tools to characterize IL-2+ CD4+ T cells during experimental autoimmune encephalomyelitis (EAE) and address their role in disease progression.